ACTG 336--STUDY OF NITAZOXANIDE (NTZ) FOR AIDS CRYPTOSPORIDIOSIS

The purpose of this study is to determine whether nitazoxanide (an investigational drug) is safe and effective for treating persons with cryptosporidiosis and HIV infection. Cryptosporidiosis is a parasite that infects the intestines of people; it can be a significant problem for persons with HIV infection. In previous studies, nitazoxanide was shown to reduce the number of bowel movements in persons with cryptosporidiosis, but more information is needed.